Dynamic integration of intracellular signaling and actomyosin contractility in the early C. elegans embryo

THIS PAGE INTENTIONALLY LEFT BLANK

Public health relevance
THIS PAGE INTENTIONALLY LEFT BLANK